Improving Research Efficiency through Better Descriptors

TR&D Project 2: Improving Research Efficiency through Better Descriptors (DESCRIBE)
SUMMARY: The scale and complexity of neuroimaging research have grown exponentially over the last three
decades and have enabled new insights into human cognition in health and disease and development of new
imaging hardware, processing, and informatics technologies. As new information has proliferated into the
research ecosystem, there is a need to integrate this knowledge from publications, data sources, and analysis
tools. This integration has been hampered by limited harmonization of description across these digital outputs.
During the current period, this Technology Research and Development Project, TR&D2, has addressed some
of these challenges. We extended the Neuroimaging Data Model (NIDM) - a descriptor framework built on top
of the World Wide Web Consortium's Provenance Data Model (W3C-PROV) and backed by community-
developed ontologies. Using such standards we also created a set of technologies with our ReproNim projects
and partners to enable reproducible analytics, to harmonize data and results, and to gather standardized
provenance. This proposal aims to increase research efficiency and overall trust in scientific findings through
better description of digital objects and better provenance of analytics. To accomplish these overarching goals,
we will: 1) Formalize detailed and structured descriptors of all stages of a neuroimaging research workflow.
This is critical for interpreting and trusting scientific results. 2) Develop a resource to create and disseminate
Findable, Accessible, Interoperable, Reusable (FAIR) and robust scientific workflows. This will enable users to
trust and reuse existing and well-tested analyses, as well as disseminate their own scripts when such analyses
are not available. 3) Extend and harden existing ReproNim technologies in coordination with the community.
We will integrate our technologies through developers of other tools, thus making our technologies more
accessible to those who have limited technical experience. This effort will be complemented by training and
support for different user experience levels and use cases. We will deliver a set of technologies that allows
researchers to harmonize their output by design, from assessment and imaging data collection to final results.
These technologies will also support consolidation and reuse of existing workflows, with new processes being
developed only when necessary. Finally, our tools will support community-based generation, curation, and
management of standardized information. We will carry out this work in collaboration with the other ReproNim
technology research and development projects, and our collaborative and service projects. Together, we will
help researchers become more effective through increased efficiency in every facet of the research lifecycle.
TR&D2 technologies support the overall mission of ReproNim to improve the way neuroimaging research is
performed and reported, to enable a comprehensive set of data management, analysis and utilization
frameworks in support of both basic research and clinical activities, and to improve the reproducibility of
neuroimaging science and extend the value of our national investment in neuroimaging research.

Public health relevance
Project Narrative A large investment in time and money is made to support neuroimaging research to understand how brain structure and function develops and ages, and how various disorders affect it. However, much of this research, while very valuable, is performed on a relatively small number of subjects and is reported in a way that makes it difficult to replicate or assess its generalization across the population. ReproNim: A Center for Reproducible Neuroimaging Computation, provides a re-executable framework for capturing data and performing neuroimaging analysis. In this renewal, we seek to improve the efficiency of this framework in support of improving all clinical and research studies using neuroimaging.